Understanding how mitochondrial interaction with other organelles in the retinal pigment epithelium (RPE) affect its function in the outer retina

Project Summary
Accumulating evidence highlights the significance of comprehending metabolic changes in the retinal pigment
epithelium (RPE) - the first site where pathogenesis occurs in many retinal degenerative diseases. The
objective of the proposed research is to gain a deeper understanding of RPE metabolism and mitochondrial
biology in both healthy and diseased states, from a cell biological perspective using state-of-the-art live
imaging methods. The results of this project will bring about novel discoveries in disease mechanisms.
The RPE is positioned between the photoreceptors and the choroid and has a crucial role in
maintaining homeostasis in the outer retina. One of the critical functions of the RPE is the daily phagocytosis of
the photoreceptor outer segment (POS). Phagosome transport is powered by ATP-dependent molecular motor
activities, while the degradation products of the phagosome serve as a source of energy. The RPE
mitochondria must adapt to these daily metabolic events.
The proposed study will investigate the molecular and functional basis of these changes through
metabolic analysis. Additionally, super-resolution high-speed live imaging and electron microscopy will be used
to analyze the behaviors of potentially different subsets of RPE mitochondria in relation to specific RPE
functions. The focus will be on three main questions: 1) How does RPE phagocytosis affect peroxisome-
mitochondria-dependent lipid metabolism? 2) What is the role of mitochondrial dynamics and interaction with
actin in the basal RPE? 3) What are the differences and similarities in the alterations of these mitochondrial
interactions in Choroideremia?
The findings of the study will be compared and contrasted with observations in human RPE cell lines
and patient-derived iPSC-RPE cultures. A perfused microphysiological organ-on-chip model will also be
utilized to imitate the outer blood-retina environment. This study will provide new insights into RPE
mitochondrial dynamics, opening up the possibility of discovering new disease mechanisms and identifying
novel therapeutic targets. The proposed research and training plan aligns with the missions of the National Eye
Institute (NEI) to prevent and treat eye diseases. The applicant's advisory committee, made up of well-rounded
experts, will provide guidance, and the applicant will have access to a wide range of scientific, career
development, and diversity training resources at UCLA. This experience will help jumpstart the applicant's
independent research career and bring her closer to her long-term goal of becoming a molecular and cellular
vision biologist at a primary research university. With her earlier background in vascular biology, the proposed
training will position the applicant as a uniquely qualified expert in the study of molecular mechanisms and cell-
cell interactions in the vision system, while also promoting diversity in academia.

Public health relevance
Project Narrative: Recent work has emphasized the importance of RPE metabolism in retinal function and health. However, little is known about the cell biology of mitochondria and its interaction with other organelles and cytoskeleton network in the RPE. The proposed study aims to employ state-of-the-art methods, including high-speed live-cell imaging to investigate how RPE mitochondrial dynamics and organelle interaction change in health and in disease.